Mechanisms of lineage plasticity revealed by YY1 deficiency.

Hematopoietic development is an ordered process in which stem cells give rise to multiple lineages.
While early progenitors can be multipotent, lineage-specific progenitors reach a stage where they
become exclusively committed to that lineage. For example, B and T cell lineages differentiate from
lymphoid-primed progenitors produced in the bone marrow, and exclusive commitment to the B cell
lineage occurs as cells transition from the pre-pro-B to the pro-B cell stage. Despite the commitment of
pro-B cells to the B lineage, we have made the surprising discovery that conditional knock-out of the
ubiquitous multi-functional transcription factor YY1 in pro-B cells, results in the loss of B lineage
commitment and the consequent ability to develop into the T cell lineage both in vitro and in vivo. To
understand the mechanistic basis for this surprising lineage plasticity, we have developed a new lineage
tracing mouse line that will enable us to determine how YY1-null pro-B cells develop into T lineage cells
(de-differentiation to more primitive progenitors, or trans-differentiation), assess the potential for YY1-
null pro-B cells to develop into other hematopoietic lineages, and determine if YY1-null T cells also
exhibit lineage plasticity (Aim 1). Mechanistically, lineage-specific transcription factors bind to DNA and
regulate gene expression prior to subsequent large-scale alterations in chromatin structure needed for
lineage commitment. Rigorous studies by our laboratory as well as others indicate that despite its
ubiquitous expression pattern, YY1 controls long-range chromatin interactions (LRCIs) in a lineage-
specific fashion. Our findings support the hypothesis that DNA binding by lineage-specific transcription
factors enables YY1 recruitment to distinct genomic loci, thereby enabling YY1 to both generate LRCIs
that stabilize lineage-appropriate gene expression, and to generate repressive chromatin marks
(H3K27me3) at lineage-inappropriate genes. We will thus, compare the molecular genetic phenotype
(gene expression patterns, chromatin accessibility, epigenetic structure, and chromatin folding) of YY1-
null pro-B cells developed into DN1, DN2a, DN2b, DN3, DP, CD4+, and CD8+ T cells, compared to wild-
type T lineage cells, as well as YY1 conditional knockout T lineage cells (Aim 2). We hypothesize that in
the absence of YY1, T lineage development can proceed, but LRCIs needed to stably maintain lineage-
specific gene expression, and heterochromatin needed for repression of alternative lineages will fail to
fully develop, potentially enabling continuing lineage plasticity. Our experiments may reveal a common
mechanism for controlling lineage plasticity, vastly expanding potential applicability of directing YY1-null
cells into multiple lineages.

Public health relevance
Our studies will determine the full hematopoietic lineage plasticity of YY1-null pro-B cells, and their developmental pathway of developing alternative lineages. Mechanistic studies will explore the molecular mechanisms of YY1 control of lineage commitment. Defects in these processes can cause hematopoietic and immune defects, and our studies may define a new general mechanism for regulating lineage commitment and development that may be applicable to other systems, and that potentially could be used therapeutically.